Novel hand hygiene product to remove Clostridioides difficile spores

7. Project Summary/Abstract
C. difficile now causes more hospital-onset infections and deaths in the US than any other pathogen and is
the most important cause of healthcare-associated diarrhea among adults in industrialized countries. In 2017,
there were an estimated 462,100 combined healthcare- and community-associated C. difficile infection cases in
the US, and 20,500 in-hospital deaths. In a randomized trial, soap and water washing for 30 seconds reduced
but did not eliminate hand contamination in patients with CDI or asymptomatic carriage of C. difficile, whereas
alcohol hand hygiene had no effect. The hands of healthcare workers frequently become contaminated with C.
difficile spores, but hand washing with soap and water has only modest efficacy, and alcohol-based hand
sanitizers have essentially no efficacy against spores. Thus, there is an important unmet need for development
of effective strategies to reduce the burden of spores on hands. Given the concern that unrecognized
asymptomatic carriers contribute significantly to transmission, there is an urgent need for comprehensive
approaches applicable to persons who directly care for CDI patients, and also more generally for all hand
hygiene.
We have developed a practical and highly innovative approach to meet this need through the development
of a sporicidal hand wash that is effective in significantly reducing C. difficile spores on skin. Our hand wash
formulation is based on the use of a new class of microstructured fluid (MSF) made with microfibrillated cellulose
which significantly enhances the removal of C. difficile spores from skin by physical and mechanical means
compared to traditional soap and water. The shear stresses generated at the skin surface during washing with
MSF are 10 to 100 times higher when compared to what can be obtained with traditional soap and water.
Importantly, we have recently discovered that when the microstructured fluid is made with the inclusion of novel
and skin-safe sporicidal ingredients at neutral pH, we are able to achieve ∼3.5 log reduction of C. difficile spores
from porcine skin in 30 seconds according to comprehensive testing. This discovery constitutes a significant
improvement over conventional soap and water, and in principal, should result in high assurance prevention of
transmitting C. difficile infection. This new discovery is significant since current alcohol-based hand sanitizers
are ineffective against C. difficile spores. This project is focused on: 1) optimizing and finalizing the MSF hand
washing formulation based on testing with an established skin model with the goal of achieving >3 log reduction
of C. diff spores and important HAI infections from skin; 2) manufacturing the MSF hand wash product under
GMP, performing compatibility/stability studies and developing quality control requirements; and 3) testing the
safety and tolerability of the MSF hand wash on skin as required by FDA.

Public health relevance
8. Project Narrative This project is directed to developing a novel skin-safe hand wash product that will significantly decrease the C. difficile spore levels on hands (>3.5 log reduction) compared to traditional soap and water hand wash which is marginally effective (1-2 log reduction), and to alcohol based hand sanitizers which are entirely ineffective. The anticipated product is based on a new class of microstructured fluid that is highly functional in removing spores and pathogens from skin by a cardinally new mechanism of action. The product is expected to provide a robust solution to prevent transmission of C. difficile and hospital-acquired infections (HAI) in healthcare and community facilities, with additional potential applications in patient bathing and skin treatment.